Research and Data Analysis Core (RDAC)

PROJECT SUMMARY – RESEARCH DATA AND ANALYSIS CORE
The Boston Health Equity & community-Aligned Learning Health System (Boston HEALHS) Center integrates
the research infrastructures of Boston Medical Center Health System and Boston University (BU) to form a
highly innovative Research Data and Analysis Core (RDAC) that supports an LHS infrastructure designed to
address health inequities and serve as an experiential training laboratory for LHS Scientists. The overarching
goal of the Boston-HEALHS RDAC is to provide scientific rigor for the Boston-HEALHS program in its
conduct, implementation and dissemination of PCOR/CER. The RDAC will link experts in community
engagement, informatics, health services research, causal inference, comparative effectiveness/patient
centered outcomes research, implementation science, equity, and research ethics together to achieve this
goal. A fundamental tenet of the LHS approach is the combination of scientific rigor with pragmatic integration
of research within usual care processes. The RDAC Core will be responsible for maintaining scientific rigor for
the Boston-HEALHS program, while working with the Administrative Core (Admin Core) to ensure relevance
and impact of embedded research, and the Research Education Core (REC) to provide experiential learning
opportunities. Specifically, RDAC will develop and apply state-of-the-art methods and data for community-
engaged participatory research, patient centered outcomes research, and embedded comparative
effectiveness, and will support the design and execution of LHS scientists’ (as well as other investigators
across the system) research projects, coordinating and consulting with the Admin Core Committees to ensure
continuous stakeholder input. Additionally, RDAC will innovate equitable implementation of evidence-informed
practices and dissemination of LHS findings. We will expand our current systems of LHS knowledge
documentation by expanding our internal catalog of health systems learning to locally organize and
disseminate LHS learning. We leverage our existing methods expertise in Community Engaged Research
within the RDAC, strengthening links between methodologists, patients, community organizations, and
researchers, in order to tackle local LHS priorities and drive positive change towards reducing health
disparities.